Role of ASXL1 in normal and abnormal granulopoiesis.

PROJECT SUMMARY
ASXL1 is an epigenetic regulatory protein that is frequently mutated in myelodysplastic
syndromes and myeloproliferative neoplasms. Mutations in ASXL1 are associated with
treatment resistance and poor prognosis. ASXL1 mutations are highly enriched in CSF3R-
mutant myeloproliferative neoplasms, disorders characterized by an increased production of
neutrophils. Despite the high frequency of ASXL1 mutations and association with poor
prognosis, there is little known about the function of ASXL1 in normal or abnormal neutrophil
production. Through single cell RNA sequencing, we identified an essential role for ASXL1 in
normal neutrophil development. In this context, deletion of ASXL1 perturbs RNA polymerase II
function and activates a Myc signaling network in the neutrophil progenitor population. The goal
of this proposal is to define the molecular mechanisms by which ASXL1 controls the neutrophil
developmental program, and to understand how truncating mutations in ASXL1 contribute to the
biology of myeloproliferative disorders. Our long-term objective is to use this mechanistic
understanding to develop therapeutic interventions that reverse the defects in neutrophil
development associated with ASXL1 mutations.

Public health relevance
PROJECT NARRATIVE ASXL1 is an epigenetic regulatory protein that plays an important role in both normal neutrophil development and the biogenesis of myeloproliferative disorders. There is a particularly high frequency of ASXL1 mutations in CSF3R-mutant myeloproliferative disorders, which are characterized by an expansion of mature neutrophils. The goal of this proposal is to uncover the molecular mechanism by which ASXL1 contributes to both normal and abnormal neutrophil production.